FRESH Network: Assisting Trenton Special School District with Understanding Contaminants in School Meals and Transitioning to Better Food Systems

Project Abstract
Trenton Special School District (Tennessee)
FRESH Network: Assisting Trenton Special School District with Understanding
Contaminants in School Meals and Transitioning to Better Food Systems
Across Tennessee and much of the country, school meals are often heavily reliant on ultra-
processed foods—items high in sodium, additives, and preservatives that can negatively
impact children’s long-term health and cognitive development. At the same time, the
Mississippi River Delta region (Tennessee, Arkansas and Mississippi) is rich in agricultural
resources, presenting a powerful opportunity to reimagine school food systems using
local, scratch-cooked, and nutritionally dense meals.
This project, supported by the FDA Research Study of Contaminants in School Meals
(U18), will pilot a transformative school meal model in participating districts across
Arkansas. The project includes nutritional and contaminant testing of both vendor-
supplied and scratch-cooked meals, robust student engagement through taste tests and
surveys, and professional development for school nutrition teams. Funding will also
support the purchase of critical equipment like combi ovens, the integration of farm-fresh
ingredients, and the development of aligned curriculum for CTE and health-related
classes.
Led in partnership with Wellness in the School, Thaden School, Healthy Flavors Arkansas
and University of Arkansas Cooperative Extension, the project will generate data-driven
insights on student preferences, meal quality, and health outcomes. The initiative aims to
empower schools to improve food safety, nutrition, and engagement while fostering
sustainable, community-rooted food systems that can serve as a national model.

Public health relevance
Project Narrative Trenton Special School District (Tennessee) FRESH Network: Assisting Trenton Special School District with Understanding Contaminants in School Meals and Transitioning to Better Food Systems Trenton Special School District in Tennessee has aligned with a group of partners that will support the district in understanding contaminants in school meals and in piloting a transformation to more scratch cooking. A research study will explore and document the school’s and its student’s experiences, measuring the impact of student engagement, meal consumption, impact on the community and on kitchen staﬀ. Importantly, the district will build relationships and supply chains with local farmers that ensure sustainability of this transformation over time. Trenton’s project partners include Wellness in the Schools, Healthy Flavors Arkansas, the Thaden School and the University of Arkansas Cooperative Extension Service.